Nutrient-sensing GHS-R in macrophage reprogramming and inflamm-aging

Summary
This administrative supplement is in regard to Dr. Yuxiang Sun grant R01AG064869-01, titled “Nutrient-
sensing GHS-R in macrophage reprogramming and inflamm-aging” (7/1/2019- 4/30/2024). During the funding
period of this award, Dr. Sun's team has been very productive; they publish 7-8 peer-reviewed papers each
year. They are the first to report the novel function of nutrient-sensing ghrelin signaling in inflamm-aging and
demonstrate that ghrelin receptor GHS-R is a major metabolic regulator and immune sensor in aging and age-
associated diseases (Aging Cell 2011; Aging 2014, Aging 2016, Adv Exp Med Biol. 2018, J of Gerontol. 2020,
Aging 2021). A new manuscript from her lab regarding the generation and metabolic/immune characterization
of myeloid-specific GHS-R knockout mice has been submitted to JCI. The results in this manuscript reveal that
GHS-R, via an insulin signaling cascade, metabolically reprograms macrophage polarization to promote meta-
inflammation. In addition, they have also made critical contributions to a Nature 2022 paper, which uncovers a
novel effect of ghrelin in monocyte-associated wound repair. The exciting discovery of ghrelin signaling in aging
immunity adds a new dimension to ghrelin biology (previously primarily known for energy metabolism), and have
profound impact on both ghrelin and aging fields. Immunometabolism is a newly emerged frontier of biological
research, relevant to vast physiological/pathological conditions. Their continued investigation of macrophage
GHS-R in inflamm-aging and age-associated diseases will help to advance the understanding of aging
immunity and to identify novel immunotherapeutic strategy to improve lifespan and healthspan.
Dr. Sun's work is largely focused on immune cells such as macrophages, a high capacity flow
cytometer is essential for immune cell studies. Due to institutional consolidation, the flow cytometer core has
been re-located to a different campus 15-20 min drive away. In addition, the core service fee has become
unsustainable, they are billed $3000-$4000/month. She did not budget core service fee in her original module
budget because it was free before the relocation. The flow cytometer issue has posed a major setback
for her team, and significantly hindered their efficiency and productivity. For the successful completion
of the NIA R01 grant, Dr. Sun's team urgently needs a flow cytometer. Dr. Sun has obtained a favorable
quote for a 4 laser 48 channel flow cytometer Cytek Aurora for $295,001. She is recently awarded an
$150,000 equipment grant from AgriLife Research at Texas A&M University that can be used toward the
flow cytometer. However, she still needs additional $145,001 for the purchase.
Dr. Sun has consulted my PO, Dr. Mulualem Tilahun. Here she is submitting this administrative
supplement application to seek NIA's support of $145,001. This critically needed equipment will have
paramount impacts on the success of this project and her collaborators/colleagues, as well as the education
and career advancement of her trainees.

Public health relevance
Project Narrative Aging is associated with increased adiposity and low grade chronic inflammation in adipose tissue and liver. We have shown that global ablation of GHS-R promotes macrophage phenotypic switch toward an anti-inflammatory state, and attenuates diet-induced obesity, adipose tissue inflammation and steatohepatitis. The goal of this proposal is to understand the roles and underpinning mechanisms of GHS- R in macrophage polarization in aging, and its effects on meta-inflammation of adipose tissue and liver.